CGC-0925, NC193-C-0065 PEDIACTRIC PHASE 11 STUDY TOPOTECAN

Study objectives include ability to determine the antitumor activity of topotecan in children with progressive or refractory sarcomas of soft tissue and bone, and neuroblastoma; and to attempt to increase the dose intensity of topotecan administered to patients enrolled by intrapatient dose escalation.